Leveraging Maps and Computer Vision to Support Indoor Navigation for Blind Travelers

Leveraging Maps and Computer Vision to Support Indoor Navigation for Blind Travelers Abstract COVID-19 has made traveling as a blind or visually impaired person much riskier and more difficult than before the pandemic. As a result, people with visual impairments may limit their essential travel such as trips to the doctor’s office, the pharmacy and grocery shopping and walks for exercise or leisure. Accordingly, the goal of this COVID Supplement, which builds on and expands the work being conducted by the parent grant, is to develop a COVID map tool that provides fully accessible, non-visual access to maps. This tool will allow visually impaired persons to explore maps and preview routes from the comfort of their home, allowing them to plan their travel along safer, less congested routes using crowdedness data. In addition, the tool will present county-by-county COVID incidence data in a fully accessible form, which will inform their travel plans over greater distances. Thus, this project will give visually impaired persons the tools and confidence to undertake safer, more independent travel.

Public health relevance
Health Relevance The COVID-19 pandemic has an especially severe impact on people with significant vision impairments or blindness. The need for social distancing and reduced touching of one’s surroundings has made traveling as a blind or visually impaired person much riskier and more difficult than before the pandemic. As a result, people with visual impairments may limit their essential travel such as trips to the doctor’s office, the pharmacy and grocery shopping and walks for exercise or leisure. These travel limitations may have adverse impacts on their physical and mental health. The proposed research would result in a new software tool that could greatly increase the confidence of the approximately 10 million Americans with significant vision impairments or blindness to undertake safe, independent travel.